Developmental Research Program

Project Summary
The Developmental Research Program (DRP) will fund small investigator-initiated projects with direct cost
budgets of between $50,000-75,000. We are guaranteeing at least $200,000 total funds per year for the DRP.
Federal SPORE funds will make up $75,000 in the first year, with possible increases in subsequent years
depending upon the availability of funds. Institutional commitment from the Dana-Farber Cancer Institute
(DFCI) will provide a minimum of $125,000 per year. Given the huge success of the DRP during the past
funding cycle, we will make every effort to add additional philanthropic dollars. In the previous Dana-
Farber/Harvard Cancer Center (DF/HCC) Breast SPORE, DRPs led to publications, grants, and clinical trials.
One of the DRP awards from the previous SPORE has established the basis of a large portion of Project 3 of
this grant, and others have formed the projects in the current proposal or have been incorporated into one of
the Projects.
The process for soliciting applications, awarding grants, monitoring research progress, and making decisions
about ongoing funding are described in this section. The DRP has a transparent peer-reviewed selection
process that incorporates defined criteria for funding decisions. The committee that oversees the process and
selects the award recipients is the Developmental Research Program and Career Enhancement Program
Awards (DRP/CEP) Review Committee. The DRP will initiate a broad call for proposals to ensure the most
promising early-phase research projects receive meritorious funding, and investigators at all DF/HCC member
institutions will be eligible to submit proposals. The DF/HCC has a large and talented investigator group to
provide a wealth of applications from which to choose, and we anticipate a robust response to each request
for applications that is announced.

Public health relevance
Project Narrative The Developmental Research Program awards will support early-phase research projects including: 1) enabling the generation of preliminary data, and 2) proof-of-concept experiments. The projects will all be focused on breast cancer research. This work should lead to more mature research projects with the goals of improving breast cancer prevention, detection, and treatment.